CANCER CENTER SUPPORT CORE GRANT

The aim of the cancer center program is to understand fundamental aspects of biology related to cancer, including gene organization and expression, cell differentiation and growth control. We are studying oncogenes and transforming proteins, the regulation of viral and cellular genes, and mechanisms of cell differentiation and development.